Hypothalamic oxytocin neuron activation rescues cardiac metabolism through cardiac cholinergic signaling in type 2 diabetes

PROJECT SUMMARY
Cardiac autonomic neuropathy (CAN) is a serious complication of type 2 diabetes (T2D) that is strongly
associated with approximately five-fold increased risk of cardiovascular mortality. CAN manifests as a decline in
parasympathetic tone and overactivation of sympathetic activity that contributes to resting tachycardia and fixed
heart rate, and myocardial infarction. Although it is a common complication, very little is known regarding how
CAN directly increases the risk for myocardial injury and disease, and thus there are no current unified treatment
algorithms other than lifestyle changes, glycemic control and management of cardiovascular risk factors. We
have recently identified a novel mechanism for restoring cardioprotective parasympathetic tone to the heart to
reduce myocardial damage in diseases with similar autonomic dysfunction, such as heart failure, myocardial
infarct, and sleep apnea. Brainstem parasympathetic cardiac vagal neurons (CVNs) receive powerful excitation
from a population of oxytocin (OXT) neurons that originate in the paraventricular nucleus of the hypothalamus
(PVN). These unique neurons co-release OXT and enhance excitatory glutamatergic neuro-transmission to
CVNs. Based upon our novel results in diseases with similar autonomic imbalances, our overall hypothesis is
that PVN OXT neuron activation is cardioprotective in type 2 diabetes. This overarching hypothesis will be tested
in two Specific Aims. Aim 1 will determine if PVN OXT neuron activation improves cardiac metabolic
flexibility by increasing glucose oxidation. Animals will be injected intravenously with heavy-carbon-labelled
glucose or palmitate to measure substrate utilization by the heart. Carbon tracing of metabolites in left ventricular
samples will reveal changes to energy utilization caused by treatment. Mass-spectrometry will be used to identify
the metabolites to test the hypothesis that OXT neuron activation improves cardiac energy metabolism as a
mechanism of protection. Aim 2 will determine if PVN OXT neuron activation improves cardiomyocyte
calcium cycling and contractility. We will test our hypothesis that PVN OXT neuron activation confers
cardioprotection by improving calcium homeostasis and contractility in cardiomyocytes. Using collagenase
digestion of hearts from Control, T2D, and Treatment animals we will use assess contractility and calcium flux
of individual cardiomyocytes with IonOptix. We will probe for changes to calcium handling protein expression
using western blot.

Public health relevance
Narrative Diabetic cardiovascular autonomic neuropathy is among the most common yet least understood complications of type 2 diabetes (T2D) despite significant negative impact on survival and quality of life. A goal of this project is to identify the effects of T2D on brainstem-originating neuronal communication to the heart in a model of high fat diet and streptozotocin-induced T2D in rats. Our studies will also test the innovative hypothesis that timed activation of a small population of hypothalamic paraventricular neurons will slow the development of, or reverse, the deleterious autonomic and cardiac function alterations that occur during T2DM.